Engineering Biomimetic Tissues for Muscle Repair

Engineering Biomimetic Tissues for Muscle Repair
Project Summary/Abstract
Skeletal muscle regeneration after severe trauma is often deficient and can lead to loss of function and disability.
This has created a significant clinical burden. Although skeletal muscle has significant regenerative capacity,
genetic defects, changes in extrinsic signaling, or substantial tissue damage can impair its capacity for self-repair.
Large skeletal muscle defects can profoundly impact the quality of life of patients by significantly reducing the
functionality of the injured muscles. Currently there is no regenerative standard of care. The long-term goal is to
develop an advanced scalable bioengineered tissue that supports muscle growth for validated drug screening
models and for therapeutic implantable muscle tissues. The objectives in this application are: to define and
incorporate critical physical and biochemical regenerative components within a novel scalable bioengineered
muscle tissue; to determine the parameters for controlled and rapid cell loading of a novel bioengineered tissue
that can sustain muscle development; and to investigate the physical and biochemical signals that modulate human
mesenchymal stem cells (hMSCs) function (in particular, blood vessel formation support) within a novel engineered
muscle tissue. The central hypothesis is that an implantable engineered tissue designed with biophysical and
biochemical properties that imitate muscle will greatly enhance muscle fiber maturation and blood vessel formation.
The specific aims are to: 1) Define the physical and biochemical features of a novel bioengineered biomimetic
tissue to develop engineered muscles for drug screening (in vitro) and muscle repair therapies for patients, 2)
Investigate an effective method for developing controlled and mature muscle fibers using an engineered biomimetic
tissue in vitro, and 3) Investigate the incorporation and function of human Mesenchymal Stem Cells (hMSCs) in an
engineered biomimetic muscle tissue to develop vascularized muscle constructs. These results will provide strong
proof of principle for further development and future clinical trials of advanced biomimetic muscle tissues, ultimately
providing new opportunities for the development of novel therapies for muscle injuries and other related clinical
needs (muscular dystrophies, congenital diaphragmatic hernia, iatrogenic skeletal muscle injuries).

Public health relevance
Project Narrative: The goal of this SC2 proposal is to advance the design and development of implantable scalable material systems for applications in muscle regeneration by investigating the interplay of complex cellular systems and the extracellular matrix components. The relevance to public health of the planned investigation entails identification and development of novel agents and or combination of agents for use as therapies for muscle tissue regeneration and to restore tissue function.